Variations in long-term fine particulate matter air pollution associations with mortality by particle size, source, and composition

SUMMARY
Mortality associations with fine particulate matter (PM2.5) air pollution exposures have been well
documented. However, the estimate as to how many deaths per unit mass are associated with PM2.5 exposure
has varied widely across studies, adding to the uncertainty of generally applying these effect estimates to new
situations for policy and health decision-making (e.g., to other cities or countries around the world). In this
work, we will evaluate how these health impacts vary with PM2.5 mass source, size distribution, and
composition in the large NIH-AARP “Diet and Health Study” cohort, comprising more than a half million older
adults living in cities and states across the United States. Participants in this cohort have been well
characterized by numerous individual characteristics (e.g., age, sex, race, presence or absence of diabetes,
height, weight and smoking), as well as by residence census tract ecologic covariates (e.g., population and
housing density, average income). The study participants have been followed since 1995-1996 for mortality,
and cause of death has been ascertained. We will enhance the NIH-AARP cohort database by determining
long-term participant PM2.5 mass source, composition, and size distribution (i.e., PM mass < 1.0 µm)
exposures, and compare their respective associations with mortality. This will allow us to innovatively test the
hypothesis that the PM2.5 mass –mortality effect estimates vary as a function of particle size, composition,
and/or source characteristics, both overall and in potentially sensitive sub-populations, enabling a more
informative assessment of excess mortality due to air pollution exposures. With this new insight, the PM2.5
health benefits can be optimized during mitigative public health and healthcare actions by considering PM2.5
source and composition, including to best protect the most vulnerable populations, and when evaluating the
clean air health benefits of alternative energy source choices to address climate change.

Public health relevance
PROJECT NARRATIVE Excess mortality has been associated with long-term exposure to fine particulate matter (PM2.5), but effect estimates of mortality per unit mass has varied widely from study to study. Using a robust study design in a large well characterized human cohort, we will evaluate the effect of PM2.5 mass, size distribution, source, and composition on the PM2.5 – mortality relationship. With this new information, the benefits and uncertainties of public health policies to protect the public from the adverse effects of environmental change will be more fully assessed, providing improved guidance for future mitigative efforts aimed at protecting health, including during climate policy and regarding the most vulnerable populations.